A Church-Based, Self-Management Intervention for Mexican-Americans with Diabetes

DESCRIPTION (provided by applicant): My long-term research objective is to become a nationally respected, independent community-based researcher, with a specific focus on using faith-based interventions to reduce diabetes disparities among Latinos. Diabetes is a very prevalent and morbid condition affecting Latinos, especially Mexican-Americans in the United States. Many church-based interventions have shown promise improving health outcomes among minority populations; but data on church-based interventions for Latino populations is scarce. Considering that the church is a center of Latino family and culture, interventions based in churches has promise to have great impact on this population. To our knowledge, no other studies have focused on designing church-based interventions for Latinos with diabetes. My research to date has already allowed me accomplish many of my short-term objectives in my path to becoming an independent academic researcher. With the support from the career development award, I will have the opportunity to refine my skills in community-based research methods and design interventions to tackle health disparities and foster change in Latino communities. I have the following short-term goals over the next five years that I will focus on in this proposal: 1) To gain additional research training and skills; 2) To assess the facilitators and barriers of local healthcare providers in linking to church-based diabetes, self-management interventions; 3) To design a church-based, culturally-appropriate patient intervention in partnership with faith-based institutions and local healthcare institutions to increase self- management of Latino patients with diabetes; 4) To pilot the intervention among Latinos with diabetes with the goal of improving their diabetes outcomes. Considering the growth of the Hispanic population and their disproportionate burden of chronic diseases, developing community based programming and linking these programs to the local healthcare system is crucial to decrease the health disparities among Latinos and has promise to have a high impact on diabetes outcomes on this community. With support from the K23 award, I can improve my skills in community based research and work towards my goal of becoming an independent academic researcher with an expertise in applying community based methods in decreasing Latino disparities in diabetes through faith-based interventions.

Public health relevance
PUBLIC HEALTH RELEVANCE: My long-term research objective is to become a nationally respected, independent community-based researcher, with a specific focus on using faith-based interventions to reduce diabetes disparities among Latinos. Considering that the church is a center of Latino family and culture, interventions based in churches have promise for great impact in this population. To our knowledge, no other studies have focused on designing church-based interventions for Latinos with diabetes. Considering the growth of the Hispanic population and their disproportionate burden of chronic diseases, developing programming to decrease the health disparities affecting this population is crucial. My research to date has already allowed me accomplish many of my short-term objectives in my path to becoming an independent academic researcher. With the support from the career development award, I will have the opportunity to refine my skills in community-based research methods and design interventions to tackle health disparities and foster change in Latino communities. Project Narrative My long-term research objective is to become a nationally respected, independent community-based researcher, with a specific focus on using faith-based interventions to reduce diabetes disparities among Latinos. Considering that the church is a center of Latino family and culture, interventions based in churches have promise for great impact in this population. To our knowledge, no other studies have focused on designing church-based interventions for Latinos with diabetes. Considering the growth of the Hispanic population and their disproportionate burden of chronic diseases, developing programming to decrease the health disparities affecting this population is crucial. My research to date has already allowed me accomplish many of my short-term objectives in my path to becoming an independent academic researcher. With the support from the career development award, I will have the opportunity to refine my skills in community-based research methods and design interventions to tackle health disparities and foster change in Latino communities. __SpecificAimsTextDelimiter__ Specific Aims Diabetes is a prevalent and morbid condition disproportionately affecting Latinos, especially Mexican- Americans in the United States. South Lawndale, a predominantly Mexican neighborhood of Chicago, has a high diabetes related mortality rate compared to the rest of Chicago and the U.S. Many church-based interventions have shown promise improving health outcomes among minorities; but data on church-based interventions for Latino populations are scarce. Considering that the church is central to Latino culture and family, interventions based in churches have great potential to impact diabetes disparities seen in this population. Considering the growth of the Hispanic population and their disproportionate burden of chronic diseases, developing programming to decrease health disparities in this population is crucial. To our knowledge, no other studies have focused on designing church-based interventions for Latinos with diabetes. Our study proposes to fill this gap. We are using a community-based participatory research (CBPR) approach and have begun to assemble a Community Advisory Board (CAB) to participate in the intervention design. The CAB currently is composed of community members, church volunteers, community partners, community health workers, and local healthcare leaders. This proposed research plan for the next five years comes from discussions with my community partners, the CAB, my own experience working with Latino communities, and with experts in diabetes research and health disparities. Using CBPR principles, the study design will be refined based on ongoing feedback from the Community Advisory Board (CAB) to make it more practical and relevant to the community. Specific Aims. Main objective: To improve diabetes outcomes among Mexican-Americans with diabetes through church-based, culturally tailored, diabetes self-management interventions linked to the local healthcare system. Specific Aim 1: To explore the facilitators and barriers to linking church-based diabetes self-management interventions to the local healthcare system. Specific Aim 2: To develop a church-based, diabetes self-management intervention for Mexican-Americans with diabetes that is linked to the local healthcare system Specific Aim 3: To pilot test a church-based, culturally tailored diabetes self-management intervention to improve diabetes outcomes among low-income Mexican-American with diabetes H3.1 A church-based diabetes self-care management curriculum partnered with the local healthcare system will improve glycosylated hemoglobin. H3.2. A church-based diabetes self-care management curriculum partnered with the local healthcare system will improve systolic blood pressure and low-density lipids. H3.3 A church-based diabetes self-care management curriculum partnered with the local healthcare system will improve diabetes related self-efficacy, self-empowerment and self-care management. With the support from the K23 award, I can work towards my goal of becoming an independent academic researcher with an expertise in applying community based methods in decreasing Latino disparities in diabetes through church-based interventions. The data from this project will set the groundwork for applying for an R01 or R18 grant in the future that will evaluate community-based interventions to improve diabetes outcomes in poor Latino communities and evaluate the sustainability of these interventions.